How SAMHD1 regulates HIV-1 innate immunity and viral gene expression

Abstract
The lack of clear mechanisms by which host proteins regulate HIV-1 innate immunity in macrophages is a
significant knowledge barrier to a functional cure for HIV-1 persistent infection. In this revised R01 proposal, we
seek to investigate non-canonical functions of the cellular protein sterile alpha motif and HD domain-containing
protein 1 (SAMHD1) in regulating innate immune responses during HIV-1 infection of primary macrophages.
Since SAMHD1 was discovered as an HIV-1 restriction factor in 2011, extensive studies have revealed the
mechanisms underlying SAMHD1-mediated restriction of HIV-1 replication in myeloid cells and resting CD4+ T
cells. In 2018, we discovered a novel function of SAMHD1 in suppressing the innate immune response to viral
infections and inflammation in macrophages. However, the underlying mechanisms of action remain unclear,
representing a significant knowledge gap given the importance of macrophages in HIV-1 persistence.
Our long-term goal is to define the functional roles and molecular mechanisms of cellular proteins, such as
SAMHD1, in regulating innate immunity during persistent HIV-1 infection of macrophages. Our overall objective
is to reveal how SAMHD1 inhibits the type I interferon (IFN-I) and NF-κB pathways in primary macrophages,
acting as a multifaceted repressor of innate immune signaling induced by viral infection. IFN-I induction plays a
key role in antiviral innate immunity; however, HIV-1 infection does not induce a strong IFN-I response. NF-κB
is critical for HIV-1 gene transcription and immune activation, and transcriptional inhibition of viral gene
expression is the main mechanism of HIV-1 latency. Thus, our central hypothesis is that SAMHD1 suppresses
innate immunity to HIV-1 infection in primary macrophages by inhibiting IFN-I induction and NF-κB activation.
Our three specific aims are: Aim 1. Define how SAMHD1 and IRF7 interaction inhibits IFN-I induction during
HIV-1 infection; Aim 2. Examine SAMHD1 interaction with MAVS and effects on anti-HIV-1 innate immune
responses; Aim 3. Investigate the mechanisms by which SAMHD1 inhibits NF-kB activation during HIV-1
infection. Our interdisciplinary studies will fill knowledge gaps to fundamentally enhance our mechanistic
understanding of SAMHD1 and associated proteins in regulating HIV-1 infection, viral gene expression, immune
activation, and anti-HIV-1 innate immune responses. Thus, our proposed studies of how SAMHD1 regulates
immune activation and HIV-1 infection in macrophages will provide new knowledge studying viral persistence.

Public health relevance
Project Narrative Studying how cellular proteins regulate HIV-1 infection and antiviral immune responses is essential for developing a functional cure for HIV/AIDS. Using interdisciplinary approaches, we will investigate functional and structural roles of several host proteins in modulating HIV-1 infection and innate immune responses. Our fundamental studies will provide new insights into the molecular mechanisms by which regulate HIV-1 replication and innate immunity.